Uncovering isoform-specific functions of RNA-binding protein Bruno1 in Drosophila muscle development

RNA regulation plays a critical role in muscle development and function. Fine-tuning isoform
expression ratios of sarcomere proteins enables muscles to acquire mature, fiber-type specific
contractile properties and to adapt to physiological demand, although the regulatory mechanisms
that direct fiber-type specific splicing are still not well understood. In diseases such as myotonic
dystrophy, mis-regulation of RNA-binding proteins including CELF1 leads to altered isoform
expression patterns and muscle malfunction. The development of new therapies will rely on a
better understanding of how aberrant RNA regulation leads to muscle disease. Our work has
helped establish Drosophila melanogaster, a tractable model organism with a powerful genetic
toolbox, as a model to study conserved mechanisms of RNA-binding protein function in
myogenesis. We have shown that the CELF1 homolog Bruno1 (Bru1) regulates fiber-type specific
splice events in indirect flight muscle. Loss or gain of Bru1 disrupts cytoskeletal rearrangements
during early stages of differentiation that are necessary for myofibrillogenesis and blocks a
developmental transition in alternative splicing to mature sarcomere protein isoforms necessary
for proper regulation of sarcomere growth and myosin activity. Bru1 as well as CELF homologs
in vertebrates are themselves alternatively spliced, but little is known about their isoform-specific
functions. Here we propose to elucidate the function of individual Bru1 isoforms during muscle
development using a multi-pronged approach integrating genetic, molecular and biochemical
techniques. Based on preliminary data demonstrating Bru1 isoform-specific phenotypes, we will
expand our isoform-specific toolbox to monitor isoform localization dynamics and test which
isoforms are required by manipulating developmental-stage dependent isoform expression. We
will uncover Bru1 isoform-specific regulatory logic by analyzing transcriptome-wide splicing
signatures in RNA-Seq complemented with Nanopore sequencing to assemble full-length
transcripts. We will verify alternative regulatory events in loss and gain of function backgrounds
with splicing reporters. We will demonstrate Bru1 protein isoform-specific binding affinity and motif
preference using EMSA and eCLIP, and test domain-specific function with structure-function
constructs. Successful completion of these aims will enable us to evaluate Bru1 isoform-specific
function in alternative splicing and translation, and demonstrate how alternative splicing of CELF
proteins fine-tunes regulatory capacity. Given the strong conservation in muscle structure and
function between flies and vertebrates, our work has the potential to identify conserved and
disease-relevant genetic principles governing RNA-binding protein function.

Public health relevance
An estimated 1 in 8,000 people are affected by the muscle disorder myotonic dystrophy, which is caused by a genetic defect that leads to muscle malfunction and mis-regulation of RNA-binding proteins including CELF1. This proposal utilizes the powerful genetic model organism Drosophila melanogaster to elucidate foundational mechanisms of CELF homolog Bruno1 isoform-specific function in RNA regulation during muscle development, including analysis of cellular and behavioural phenotypes, identification of transcriptome-wide regulatory signatures, and biochemical evaluation of RNA target binding affinity and preference. Considering the high level of conservation from flies to humans in muscle structure and function, our results will advance understanding of CELF factor regulatory dynamics in myogenesis and have the potential to provide human disease-relevant insight into isoform-specific function of CELF family proteins.